BLR&D Research Career Scientist Award Application

The major area of our research is to help understand the causes of, and development
treatments for neurodegenerative diseases and conditions, in particular Alzheimer’s
Disease (AD) and Multiple Sclerosis (MS). This work includes repurposing drugs that are
FDA-approved for other indications but we show can provide benefit in animal models of
AD and MS, making it easier to bring them to the clinic. A better understanding of how
these diseases start and evolve, and identification of interventions will help reduce
disease symptoms, as well as social and economic burdens. Our MS studies currently
funded by a Merit grant have expanded into the area of genetic risk factors that may
predispose one to developing MS, based on our findings of a novel nucleotide variant in
one particular gene. We are now determining how the variant increases risk using cell
cultures and a mouse model that we developed to replicate the human variant, and testing
drugs to see if they can minimize its effects. We are also testing if this variant, or others,
is present at higher frequency in certain veteran populations, including in African
American, Hispanic, and Caucasian cohorts. At the same time in work funded by the
National MS society, we are testing a novel compound in a mouse model of MS we
believe will reduce neuronal damage and also increase the myelin sheath that surrounds
and protections nerve cells.
We are also working on a project to evaluate the consequences of excessive alcohol
consumption on the development of AD. We found that exposing brain ‘support’ cells (glial
cells) to ethanol reduces their ability to clear amyloid plaques; we plan to extend those
cell studies to a mouse model of AD. We have also been funded to carry out studies that
may have particular importance to our active military as well as veteran population,
namely studies on possible neurological damage caused by commonly used anti-
coagulants (e.g.warfarin), and also more potent ‘superwarfarins’ that are used as
rodenticides, but unfortunately have also been used in military situations. We are
developing methods using FDA-approved drugs, we hope will prevent the toxic effects of
these drugs as well as long term consequences.

Public health relevance
The number of veterans afflicted with MS is estimated at about 30,000; and some studies have suggested that the incidence of MS is higher in certain veteran populations than in civilian populations. Knowledge of specific genetic factors that are a risk for MS, as well as finding new treatments could help reduce minimize MS rate and symptom severity in patients. With increasing age, more and more veterans will develop AD, possibly at higher rates due to environmental factors or dietary factors, which will create new challenges for the VA healthcare systems. Our studies on the relationships between alcohol consumption and AD, or exposure to warfarins or superwarfarins and development of treatments to minimize their detrimental effects, could therefore help prevent the overall increase in AD rates.